The effect of circadian-disrupting environments on sleep and binge-like eating behavior.

Project Summary/Abstract
The brain both encodes information to drive normative functions and decodes abnormal information to
navigate sustenance and homeostasis in suboptimal conditions. This regulatory role is strongly influenced by
the body’s circadian rhythms that link the light-dark cycle of our planet with internal physiology. We do not yet
understand how the brain translates disruptions to the light-dark cycle (e.g., from our industrial environments
that can have light during the biological night) to regulate two fundamental behaviors required for life: sleep
timing and eating, both of which are circadian-regulated.
One recent approach to this problem (from the Richardson lab) is the fragmented day-night (FDN) model, in
which within each 24-hour cycle, there are four cycles of 4 hr Light + 2 hr Dark (4:2 LD) (total 16:8 LD in 24
hrs). The mode of introduction of this light-dark protocol (suddenly: FDN-S or gradually: FDN-G) determined
dramatically different phenotypes of locomotion in mice, even though the resulting light-dark environments are
identical. This suggests that the brain modifies behavior to the same environment based on how the
environment is presented. We hypothesize that the FDN-S and FDN-G environments will also differentially (i)
negatively impact sleep and eating behavior timing and (ii) change neuronal activation and gene expression in
key brain regions. To address these hypotheses, we ask the following questions: Compared to consolidated 16
hours of light and consolidated 8 hours of darkness (i.e., Control), 1) How is sleep timing, a major restorative
circadian-driven behavior, affected by the FDN-S vs FDN-G environments? 2) How is eating behavior timing,
which is circadian-regulated, be impacted during FDN-S and FDN-G environments when mice are challenged
with a binge-eating paradigm? 3) Is there a difference in neuronal activation and gene expression levels in
FDN-S vs FDN-G in brain regions involved in sleep and eating behavior timing?
We will accomplish our goals using (i) the PiezoSleep Mouse Behavioral Tracking System to record sleep, (i)
the binge-eating test to study eating behavior, (iii) c-fos immunohistochemistry to study neuronal activation,
and (iv) dPCR for gene expression using wildtype (WT- C57BL/6NCrl) adult male and female mice. The brain
areas of focus associated with sleep and circadian-regulated eating behavior will be the suprachiasmatic
nucleus (circadian light-response), ventrolateral preoptic nucleus (sleep initiation), lateral habenula (stress-
related induction of sleep), paraventricular nucleus (stress/eating behavior) and arcuate nucleus (eating
behavior). This study is innovative because it uses the same amount of light and dark exposure within 24
hours to yield three activity patterns. This work is crucial for understanding how the brain responds to the same
stimulus (e.g., light) depending on how the stimulus is presented (specific LD cycles). Together with the 3-year
development plan, the proposed study will serve as a unique research experience for the talented
undergraduate students at Oakwood University on topics integral to their daily lives: light, sleep, and eating.

Public health relevance
Project Narrative The day-night cycle on our planet strongly influences our body’s circadian system, which regulates sleep and appetite, although strong individual differences can still be observed even among members of the same household environment. Such unexplained variation can be examined precisely using a controlled, but disruptive, light-dark paradigm developed by our laboratory that yields two different circadian phenotypes in mice. Such studies can inform models of sleep patterns and binge eating that contribute significantly to public health crises connecting long-term sleep loss with risks associated with diabetes, heart and blood pressure disorders, and cancer rates, among others.